Community Outreach and Engagement

PROJECT SUMMARY/ABSTRACT
The Community Outreach and Engagement Core (COE) of Perlmutter Cancer Center (PCC) at NYU Langone
Health uses participatory and social determinants of health approaches to engage communities in our catchment
area, which spans three boroughs in New York City (NYC) and all of Long Island. COE aims to eliminate cancer
incidence and outcome disparities in historically underserved and minoritized populations. We focus on specific
cancer burdens and disparities in our catchment area, which include: 1) a high burden of lung, colorectal, breast,
and prostate cancer across all areas and groups, 2) particularly high rates of oro-digestive, microbe-related
cancers (head and neck, cervical, stomach, liver, and colorectal) in Asian, Black, and Hispanic/”Latine”
communities, 3) enrichment of specific cancer subtypes, such as triple negative breast cancer and highly
aggressive prostate cancer, in Black, Latine, and Ashkenazi Jewish communities, and 4) increasing trends of
liver, melanoma, pancreas, and lung cancers in NYC. COE is guided by the following Thematic Aims: a) to
identify and characterize the cancer burden and disparities in the PCC catchment area, b) to communicate
community needs to PCC research programs and catalyze high impact science, c) to engage the PCC catchment
area in cancer clinical trials and cancer prevention and control research, d) to disseminate PCC research and
evidence-based cancer prevention and control guidelines through culturally tailored approaches to reduce
longstanding cancer disparities in the catchment area, and e) to promote policy translation and dissemination of
PCC research findings and evidence-based strategies. Directed by Chau Trinh-Shevrin, Dr. PH, with co-leaders
Simona Kwon, Dr. PH and Joseph Ravenell, MD, national leaders in health equity research, COE is guided
by a diverse and robust Community Advisory Board to support community-driven PCC research and a Brooklyn
Community Cancer Action Network to lead signature initiatives in its catchment area. By collaborating closely
with community stakeholders, COE ensures a culture of inclusiveness and equity and supports bidirectional
communication between PCC catchment area communities and researchers to advance high impact science.
Major contributions during the funding period include the dissemination of best practices for community health
worker-driven patient navigation strategies and advancing a social determinants of health approach to cancer
prevention, screening, and control. Proposed strategies for the next cycle will enhance community outreach and
recruitment into cancer clinical trials and community-driven research initiatives that will inform national efforts to
reduce cancer disparities.